PancreasFest 2024

SUMMARY
Advancing our understanding of human pancreatic diseases, especially pancreatitis and pancreatic cancer,
requires the cooperative effort of a network of clinical centers of excellence and the regular meeting of thought
leaders in the field. The course objectives for PancreasFest 2024 will enhance progress on meeting research
priorities highlighted by the National Commission of Digestive Diseases. Specifically, we will 1) Critically review
advancements in medical, endoscopic and surgical managements to pancreatic diseases; 2) Critically review
acute and chronic pancreatitis basic and clinical research; 3) Discuss strategies for translation of new scientific
discoveries into clinical trials and practice, including needs analysis.
The University of Pittsburgh has organized and hosted PancreasFest and its precursors since 1994. CAPER
(Collaborative Alliance of Pancreatic Education & Research) was responsible for organizing PF in 2023 and
will be the main organizer moving forward, CAPER is a nonprofit devoted to enhancing the career development
of junior physician scientists in the field of pancreatology.
PF focuses exclusively on fostering translational multi-center programs for pancreatic disorders. Attendees of
past meetings uniformly praise PancreasFest for fostering collaborative research and for its emphasis on the
importance of a small conference focused on pancreatic disorders. Multiple clinical working groups have
emerged over the years through PancreasFest that focus on areas of NIDDK interest. Approximately 250+
medical professionals from varied medical disciplines register for PancreasFest each year, including
physicians and scientists interested in the pancreas: pancreatologists, endoscopists, surgeons, radiologists,
pathologists, molecular biologists, pediatricians, geneticists, epidemiologists, statisticians, systems biologists,
subspecialty medical professionals, and experts in biomarkers. We encourage attendance from new faculty
and fellows to ensure that the next generation of pancreatic investigators works directly with and learns from
senior researchers in the field. Key staff from the NIDDK are invited to provide perspective and discuss
priorities. PancreasFest is also attended by representatives from industry and patient-focused foundations,
such as CAPER, Mission:Cure, and the National Pancreas Foundation.
PancreasFest 2024 will be held at the Westin Hotel, Cincinnati Ohio July 25-27.

Public health relevance
NARRATIVE PancreasFest 2024 will benefit patients who deal with pancreatitis, pancreatic cancer, and other pancreatic disorders by providing a forum for leading experts in the field of pancreatology to present updates, discuss results of current research and inform clinical practice. No other conference focuses on these disorders from a translational research and clinical implications perspective. The meeting format encourages all attendees to participate in discussion related to providing the best possible clinical care.